Regulation of osteocalcin secretion and its therapeutic implication

Project Summary- Project #1- Lead PI- Karsenty
Since its purification in the late 70s, osteocalcin has traditionally been viewed as a structural component of the
bone extracellular matrix (ECM) that might possibly be implicated in bone mineralization. The emergence of
genetics in model organisms has allowed us and other to study the function of this protein in vivo and in the
entire animal. This investigation, which was conducted nearly 30 years ago in one mouse of osteocalcin
deficiency and reproduced in the last year in two other mouse strains of osteocalcin deficiency, allowed us to
make three types of conclusions. The first one is that bone mineralization is not affected to a level that becomes
clinically relevant in the absence of osteocalcin in the mouse. A second one that is the topic of this application
and was also observed in rats lacking Osteocalcin is that osteocalcin is an inhibitor of bone mass accrual. This
phenotype has never been explained since its initial description in 1996. A third observation again established
in three mouse models of osteocalcin deficiency is that regardless of sex, genetic background, age, mode of
generation, and analysis of mice, osteocalcin is a hormone with a remarkably broad reach. Two characteristics
of osteocalcin as a hormone led us to revisit the high bone mass phenotype of Osteocalcin-/- mice. The first one
is that for most functions it regulates osteocalcin acts as a regulator of other hormones or neurotransmitters.
That actually perform the function under study. A second characteristic is that osteocalcin signaling in the brain
regulates the production of brain-derived serotonin. Since serotonin does not cross the blood-brain barrier, this
latter observation raises the prospect that osteocalcin might also regulate the synthesis of gut-derived serotonin,
which is initiated by Tryptophane hydroxylase 1, an enzyme present in enterochromaffin cells of the gut but not
in neurons of the brainstem where serotonin is also synthesized. This observation becomes relevant to this
project because gut-derived serotonin is an inhibitor of bone mass accrual. Testing this hypothesis revealed that
osteocalcin indeed regulates gut-derived serotonin production and circulating serotonin levels, thus revealing
the existence of a reciprocal cross-talk between bone and the gastrointestinal tract that may regulate bone mass
accrual. To test this hypothesis, we enlisted the help of a world expert in intestinal epithelium physiology (Dr.
Kelley Yan). We gathered all the genetic and molecular tools needed to test our working hypothesis. Our Specific
Aims are:
 To demonstrate in consultation with Project 2 and the help of core B that osteocalcin regulates bone
mass by regulating gut-derived serotonin synthesis before and/or after birth.
 To identify and study the function of the receptor of osteocalcin expressed in enterochromaffin cells and
that mediate its regulation of the synthesis of gut-derived serotonin.
 determine with the help of Core C the mechanisms used by osteocalcin signaling to regulate serotonin
production by the gut epithelium.